Core C: Proteomics and Analytical Biochemistry Core

Core C: Summary/Abstract The proteomics and analytical biochemistry core C provides essential technical support for all three of the projects in our program. The main functions of Core C are to provide: (i) support for determining post- translational modifications (PTM) in cardiac tissue (human from Core B, rodent and rabbit) with an emphasis on sarcomeric proteins utilizing 2D-DIGE, 2D-PAGE and Pro-Q staining; (ii) separation of cardiac proteins or peptides in solution by OFFGEL fractionation; (iii) mass spectrometric (MS) analysis support to identify proteins and their (PTMs) along with multiple reaction monitoring (MRM) for targeting specific PTMs; (iv) support for identifying reactive oxygen species (ROS) induced protein modifications by Oxyblot, 2D-diagonal gels, glutathionylation Western blot assays and biotin switch assays; (v) support for determining global changes in both protein abundance and PTMs by iTRAQ/TMT labeling of either the whole proteome or sub-proteomic fractions. Core C also prepares sub-proteomic fractionation of the sarcomeric proteins or whole heart homogenates for proteomic characterization. To ensure productivity and progress, Core C support provides state-of-the-art facilities and equipment such as the Orbitrap Velos Pro and the AB Sciex 6500 Q-TRAP for advanced proteomic analysis required by all projects in the program. Core C support is critical to approach for aims in each of the projects and thus is indispensable for the overall success of the program.

Public health relevance
Core C: Narrative Core C provides vital support to determine protein modifications for each of the individual projects of the program, which will lead to a better understanding of cardiac disease progression. Determination of protein modifications by Core C will help establish novel mechanisms of cardiac growth, efficacy of drug and genetic interventions in cardiac maladaptation along with novel model systems of cardiac disease that will aid in the knowledge base and therapy of cardiac disorders.